ORAL VS J-TUBE ADMINISTRAION OF CYCLOSPORIN A IN LIVER TRANSPLANT PATIENTS

In this study, cyclosporine is being administered in two different ways to help determine the location of cyclosporine absorption. Our test will see if cyclosporine is absorbed by J-tube as well as it is orally for the purpose of administration at the post-transplant period.